The role of TCR, ligand, and signal strength in human γδ T cell development

PROJECT SUMMARY/ABSTRACT - PROJECT 2
The critical role played by γδ T cells in host defense and immunopathologies has been well-established and the
unique features of γδ T cells are being harnessed for emerging cellular therapies. While there has been much
effort in characterizing mouse γδ T cell development, very little is known about the regulatory mechanisms that
control human γδ T cell selection and functional diversification into type 1 (IFN-γ+TBET+) and type 3 (IL-
17+RORγT+) effector fates. Despite views that human and mouse γδ T cells are poorly conserved based on
distinct TCRγ and TCRδ loci, our preliminary analysis of public genomics data suggests an alignment in the role
for TCR signal strength and downstream pathways during mouse and human γδ fate specification. To investigate
this possibility, we are capitalizing on the strengths and synergy between the Ciofani and Adams labs. This
collaboration creates an unprecedented opportunity to interrogate the links between TCR ligand engagement,
TCR signal strength, downstream regulatory networks, and developmental outcomes during primary human γδ
T cell differentiation at single-cell resolution and at genome-wide scale. Using human γδTCR/ligand models
established in the Adams Lab and using the developmental and genomics expertise of the Ciofani group, we will
directly test the effect of TCR signal strength on human γδ T cell selection and regulatory programming, parallel
to the proposed work of Projects 1, 3, and 4 in mouse models. We focus on CD1d and HLA-A2, ligands that
have been characterized biochemically, structurally, and functionally by the Adams lab (the latter in collaboration
with Project 3). Both the Adams and Ciofani labs have access to healthy pediatric human thymic samples
through Biobanking programs at their respective institutions. Here, we propose an integrative approach to define
the role of TCR, ligand and signal strength during human γδ T cell development. In Aim 1, we will couple scRNA-
seq with detection of antigen-specificity via engineered barcoded tetrameric reagents (CITE-seq) to directly test
the influence of TCR engagement of known γδ T cell ligands in repertoire honing, and the developmental and
effector status of γδ thymocytes in vivo. The goal of Aim 2 is to directly test the role of TCR signaling strength
on γδ T cell selection and effector fate using a reductionist approach in vitro. We will employ an array of well-
characterized γδTCR-ligand pairs of various affinities and signal outputs in the context of the OP9-DL4 T cell
differentiation system (with Project 3) to assess how modulation of TCR signal strength influences human γδ
versus αβ lineage specification. Lastly, in Aim 3, we will identify the regulatory networks that translate differences
in TCR signal strength into γδ T cell fate. For this, we propose a novel multimodal single cell mRNA gene
expression and high-throughput reporter assay (scSTARRseq) that will allow us to simultaneously map cellular
states and profile the activity of thousands of cis elements to capture the regulatory associations between TCR
signal strength and γδ versus αβ developmental trajectories. Altogether, this proposal will establish a
comprehensive understanding the regulatory mechanisms governing human γδ T cell development.